Trophoblast miRNAs Inhibit Invasion and Angiogenesis in Fetal Growth Restriction

PROJECT SUMMARY/ABSTRACT
This K08 proposal presents a comprehensive five-year research and career development plan to address critical
questions pertaining to impaired placentation associated with fetal growth restriction (FGR). As a pediatric and
fetal surgeon, this research project, along with its accompanying didactic efforts will equip me with unique cross-
disciplinary skills to facilitate my transition to independence as a physician-scientist in placental biology.
The catalyst for this proposal is based on the rigor of previous research and our preliminary data in the field.
FGR is a significant problem that carries a high rate of perinatal mortality and a high frequency of lifelong poor
health. Pathology of fetal growth restricted placentas demonstrates reduced extravillous trophoblast invasion
and poor feto-placental angiogenesis. In addition, microRNAs, which are short non-coding RNAs, have been
implicated in the pathogenesis of FGR. They can be exported from one cell to communicate with and induce
effect on other cells via small transporters known as extracellular vesicles (EVs) and are critical for normal
placentation. Based on these data, our central hypothesis is that anti-angiogenic miRNAs within human
extravillous derived EVs inhibit extravillous trophoblast invasion and feto-placental endothelial
angiogenesis through paracrine signaling, resulting in FGR. In Aim 1, we will model the metabolic stress
associated with FGR by culturing extravillous trophoblasts in a nutrient restricted media. The miRNA cargo within
extravillous trophoblast-released EVs will then be sequenced to determine the effect nutrient-restriction has on
anti-angiogenic miRNA expression. In Aim 2, nutrient-restricted EVs derived from extravillous trophoblasts will
be incubated with extravillous trophoblasts and microvascular endothelial cells (MVECs) to determine if their
cargo impairs trophoblast invasion and placental feto-placental angiogenesis, respectively. Lastly, in Aim 3, we
will utilize a blastocyst trophectoderm transduction model to upregulate anti-angiogenic miRNAs only within the
placenta. We have previously identified miRNAs that are upregulated in mouse FGR placental tissue and will
determine their effects on implantation and fetal growth in this novel in vivo model of pregnancy.
The proposed experiments will impact multiple clinical disciplines including obstetrics, neonatology, and fetal
care by providing mechanistic data relevant to the role of miRNAs in placental pathologic changes evident in
FGR. This foundational work will provide an excellent vehicle for my maturation into an independent investigator.
Experiments will be performed in an environment with an established history of successful mentorship of junior
faculty to independence. With the support of this application, I will 1) advance my technical skills (RNA-
sequencing, invasion assays, angiogenic assays, and blastocyst transduction) and 2) learn advanced molecular
principles and biostatistics and improve my mentoring and writing skills.

Public health relevance
PROJECT NARRATIVE Fetal growth restriction (FGR) is a common pregnancy complication associated with high rates of perinatal mortality and lifelong poor health for affected offspring. Successful placentation depends on the invasion of extravillous trophoblasts into the decidua, along with the establishment of feto-placental blood vessels, both of which are frequently disrupted in pregnancies complicated by FGR. Utilizing complementary in vitro and in vivo experiments, this proposal aims to determine the impact of upregulated anti-angiogenic microRNAs from extravillous trophoblasts on these placental processes.